Federated learning algorithms to overcome statistical and algorithmic bias and privacy concerns in machine learning for health

Project Summary
Federated learning has emerged as a promising technique in biomedical research, providing the potential
to construct robust common machine learning models with datasets from multiple institutions without having
to share data among groups. However, the current implementations of this technique present several
challenges that must be addressed before it can be widely adopted in the field of biomedicine. These
challenges include issues related to bias and data heterogeneity, privacy and security, and interoperability
among institutions. To mitigate these challenges, it is essential to integrate domain-specific knowledge with
the theoretical advances in computer science and statistics for bias correction and privacy preservation. In
this regard, we propose new mathematical and algorithmic approaches that can make federated learning a
practical reality in biomedical research. These methods include developing domain-specific add-on
algorithms to traditional federated learning frameworks, and leveraging techniques such as optimal
transport and secure multiparty computation to overcome statistical and algorithmic bias, and privacy
concerns. To this end, we will first develop a framework to calculate optimal transport cost of the data
distributions across sites. This cost will be used to determine whether addition of a site to the federated
learning is beneficial to the resulting model. We will then use this cost during the learning process as a
regularization in order to take into account different data distributions in the resulting model. We will also
use the metadata from the sites in the federated averaging process to avoid bias in the resulting model.
Lastly, we will develop federated data pre-processing frameworks using secure multiparty computation to
overcome the privacy issues.

Public health relevance
Project Narrative Federated learning is a technique that allows researchers to build common machine learning models without sharing data. However, current implementations present challenges related to bias, data heterogeneity, data privacy, and interoperability among institutions. We propose new mathematical and algorithmic approaches to make federated learning a practical reality in biomedical research by developing domain- specific add-on algorithms that leverage techniques such as optimal transport and secure multiparty computation to overcome statistical and algorithmic bias and privacy concerns.